Single cell transcriptomics identifies a dentate granule cell type switch in epilepsy

PROJECT SUMMARY
After exposure to an epileptogenic insult, there may be a progressive reduction in seizure threshold that
ultimately results in spontaneous seizures; this gradual process is called epileptogenesis. There are no drugs
that modify the course of epileptogenesis; anticonvulsant drugs that suppress seizures do not work to modify
disease progression7,8. Thus, there is a pressing need to identify molecules and pathways that are at the heart
of epileptogenesis. This proposal addresses this unmet need.
Combining our powerful novel algorithm, MAGIC9, with a unique, statistically powered single cell dataset from 2
rodent epilepsy models, we have identified those nuclear proteins that control the transcriptomes in every major
cell type in the brain. This has allowed us to generate a regulatory hierarchy controlling large scale gene changes
after status epilepticus. We now have insight into all the major drivers of gene changes in epilepsy across brain
cell types. We find that DGs are the most transcriptionally altered neuronal cell type after SE and undergo a
subtype switch from ‘quiet’ to ‘active’ DGs. The transcription factor STAT3 hijacks the DG gene network to
become the hub, or apex factor that controls in excess of 90% of all information flow in the DG gene regulatory
network. The major impact of this study will be the answering of the question ‘is the DG cell type switch in
epilepsy sufficient and/or necessary for disease progression?’. The major gaps in our understanding of the role
of this pathway are 1) in which cell types does STAT3 activation occur? 2). Is STAT3 activation sufficient to
drive disease?
The premise of this project is three-fold: Firstly, our recent work (in review at time of submission) and that of
others, implicates STAT3 as a central factor in acquired epilepsy. Secondly, our preliminary data shows that
many cell type are altered in epilepsy with DG cells the most perturbed. Molecular alterations in neurons are
coordinated by activation of the transcription factor STAT3. Thirdly, pharmacological inhibition of the STAT3
upstream kinase JAK1 with the orally available, FDA approved drug CP690550 (Tofacitinib) profoundly
suppresses spontaneous seizures in our WT model. Thus, we will test whether STAT3 induction in DGs is
sufficient and/or necessary for disease progression.
The innovations of this project are: 1) We are the first to apply MAGIC to snSeq data and identify drivers of
transcriptional programs across cell types in epilepsy. 2) To our knowledge, our snSeq data is the most
statistically powered and deeply annotated epilepsy and control dataset in existence with 150,000 cells and
nearly a billion datapoints.
Successful outcome of this risky and exploratory R21 proposal will be: 1) The first exploration of the sufficiency
and necessity of the DG cell switch in epilepsy. 2) A suite of data to support a full, well-premised RO1 application.

Public health relevance
PROJECT NARRATIVE Leveraging the novel transcriptome mining tool MAGIC, combined with a unique single cell seq resource of normal and epileptic brains, we have discovered that Dentate Granule cells (DGs) undergo a robust cell type switch after Status Epilepticus. The driver of this cell type switch appears to be the transcription factor STAT3. We propose to test whether STAT3 activation during SE is sufficient and/or necessary for the DG cell type switch and whether the switch is sufficient and/or necessary to drive disease.